Cellular bases of noncoincidence learning in Hermissenda

DESCRIPTION (provided by applicant): We will study cellular processes underlying non-coincidence learning and conditioned inhibition in the mollusk Hermissenda (H.c.). This fundamental, but poorly understood category of associative learning can be readily produced in H.c., by exposing animals to a classical conditioning procedure where light (the CS) signals the absence of rotation (the US). Explicitly unpaired (EU) presentations of light and rotation increase animals' phototactic behavior. We will continue to characterize the persistent excitability changes that are produced in Type B and A photoreceptors within the CS-pathway. We have found that ocular Type B cells from EU-trained, but not control-condition, animals exhibit persistent decreases in their steady-state depolarizing generator potentials (SSGPs), and decreases in light-evoked spike frequencies. We will complete our studies demonstrating that Type A cells show complementary changes with EU-training: increases in SSGPs and light-elicited spike frequency. The ionic bases of the changes in photoreceptor excitability will be studied using voltage-clamp, ion substitution, and pharmacological methods. We will complete our studies that indicate that the decreased excitability of B cells is due to persistent increases in somatic K+ currents (IA and IK-Ca), and further characterize the mechanisms responsible. The contribution of calcium-dependent processes to expression of B cell photoresponse changes will be studied, as well as the contribution of changes in IA to the EU decreases in spike frequency. We will also determine the ionic conductance changes responsible for the increased excitability of Type A cells. We will test for the occurrence of EU-produced changes in synaptic transmission between B-B and B-A photoreceptors, through simultaneous intracellular recordings from pre- and postsynaptic cells on retention days following learning. We will continue our studies of the induction of decreases in B cell excitability, through the use of an in vitro conditioning protocol, and will test for the involvement of calcium, protein phosphatase 1 (PP1), and arachidonic acid (AA) in the production of the EU-associated decreases in B cell excitability. Because temporally-varying [Ca2+]i levels may be a crucial factor as to whether B cells exhibit excitability decreases or increases due to different stimulation regimens involving light and rotation, we will measure B cell [Ca2+]i levels at different time points following light. Ratiometric fura-2 imaging methods will be used to see if the interstimulus intervals that result in successful EU-conditioning match a specific [Ca2+]i level.